Multi-Omics at the Intersections of Environment, Diabetes, and Kidney Disease: A Multi-Omics for Health and Disease Study Site

ABSTRACT
End stage kidney disease (ESKD) is among the top contributors to mortality in the US population. Nearly 40%
of ESKD is caused by diabetes, with a natural history that includes three transitional stages: 1.) Development
of diabetes; 2.) Initiation of diabetic kidney disease (DKD); and 3.) Progression of DKD to end-stage disease.
Despite the public health burden posed by ESKD, interventions to preserve kidney function in patients with
diabetes are limited. Black and Hispanic groups face higher burdens of diabetes and more rapid progression to
ESKD than White, non-Hispanic groups. Social determinants of health (SDOH) and other environmental
exposures (e.g., metals) are important contributors to these disparities. However, the mechanisms linking
environmental exposures to DKD are unclear. Research to integrate environmental data into the multi-omics
framework is needed, particularly in Black and Hispanic communities, who suffer from excessive ESKD and
are burdened by life-long, adverse environmental exposures. Our goal is to establish a diabetes and kidney
disease study site (DSS) comprised of 300 racially and ethnically diverse adults, including 200 with
diabetes (half of whom also have kidney disease) and 100 healthy controls. Our DSS will be part of a
collaborative initiative to advance the application of multi-omics technologies to study health and disease in
ancestrally diverse populations. We will actively engage with this consortium to develop generalizable study
protocols, ranging from participant recruitment to integrative analytic pipelines that can be shared and
deployed in the cloud. To successfully recruit 300 study participants (Aim 1), we will leverage our established
recruitment infrastructure, utilizing an innovative selection strategy that will enrich our sample for those most
likely to transition across DKD stages. Thirty DKD cases will be dually recruited with the UIC Kidney Precision
Medicine Project (KPMP), enabling linkage to rich KPMP kidney tissue histopathology and multi-omics data in
a subsample of DKD cases. Our sample will reflect the diversity of our health system, which includes a patient
population that is predominantly non-White (~80%). We will further leverage our extensive clinical research
experience to collect biospecimens and obtain detailed information on environmental exposures, outcomes,
and other covariables annually for three years (Aim 2). Collected blood specimens will be used to carry-out
genomic, epigenomic, transcriptomic, proteomic, and metabolomic profiling among all study participants (Aim
3). Utilizing pipelines and integrative analytic protocols developed in collaboration with the consortium, we will
identify molecular profiles linked to environmental exposures and kidney histopathology and examine their
associations with each stage of the DKD course (Aim 4). We expect our DSS to have important research
impacts, contributing critical information towards the general advancement of integrative systems biology
research methods and elucidating novel biological mechanisms and biomarkers for DKD.

Public health relevance
PROJECT NARRATIVE Our goal is to establish a diabetes and kidney disease study site (DSS) comprised of 300 racially and ethnically diverse participants, including 200 with diabetes (half with kidney disease) and 100 healthy controls. Our DSS will be part of a collaborative initiative with an overall mission to advance the application of integrative multi-omics technologies to study health and disease in ancestrally diverse populations.